CHARACTERIZATION OF ASTROVIRUS VA1, A NOVEL NEUROTROPIC VIRUS

Project Summary/Abstract
This mentored career development award (K08) proposal describes the research and educational plans
for the candidate, Andrew Janowski MD. His long-term goal is to discover and characterize viral causes of
central nervous system (CNS) infection. One entity, encephalitis, is often caused by infectious pathogens, but
frequently an etiology cannot be identified despite extensive clinical testing. A subset of encephalitis cases are
anticipated to be caused by novel viruses or viruses with an unappreciated neurotropism. Dr. Janowski has
previously used next-generation sequencing technology to discover a novel family of viruses named
statoviruses and has also increased the number of known RNA bacteriophages by over six-fold. He will apply
these skills to identify novel pathogens in CNS infections and to characterize their biology.
Astrovirus VA1 (VA1), a virus originally discovered by Dr. Janowski's mentor, David Wang PhD, has
been identified as an emerging cause of encephalitis. However, studies of the fundamental biology of this virus
has been precluded by the lack of an experimental model of infection. Dr. Janowski has developed the first cell
culture model of VA1 infection in vitro, and now the biology of VA1 infection can be elucidated using this
system. In Aim 1, he will develop an in vitro model of VA1 CNS infection. He will define host expression profiles
upon infection and determine if there are any VA1 strain specific cellular tropisms. The host immune response
to VA1 infection is also poorly defined, but preliminary evidence suggests that interferon-β is induced by VA1
and addition of exogenous interferon reduces VA1 replication. For Aim 2, Dr. Janowski will use a CRISPR/Cas-
9 approach to define pattern recognition receptors and interferon stimulated genes that mediate the interferon
response. In Aim 3, Dr. Janowski will use a neutralization assay to define the seroprevalence of neutralizing
antibodies to VA1. He will also use a qRT-PCR assay to define the burden of CNS diseases caused by VA1,
as he has a repository of clinical specimens from patients with acute CNS diseases.
Characterizing VA1 will prepare Dr. Janowski to transition as an independent physician-scientist by the
end of the K08 award period. His career development will be overseen by his co-mentors, Drs. David Wang
and Gregory Storch, with Drs. Robyn Klein, Herbert “Skip” Virgin, Mike Diamond, and David Hunstad forming
an illustrious advisory committee that will assist in career development and experimental design. In addition,
Dr. Janowski will complete a master's degree in clinical investigation in translational medicine at Washington
University in St Louis to enhance his formal scientific training. He has the support of a world-class institution,
an outstanding group of mentors and advisors, a well-developed educational plan, and a research project that
will provide unique and provocative results regarding the biology of VA1. The results of this K08 proposal will
not only build upon host-virus interactions in CNS infections but it will launch the independent research career
of Dr. Janowski.

Public health relevance
Project Narrative Astrovirus VA1 is a newly recognized neurotropic virus from cases of human encephalitis, but the biology and spectrum of neuroinvasive disease caused by this virus is undefined. This K08 career development award describes the research plan for characterization of astrovirus VA1 during the candidate's five-year career development plan as he transitions into an independent physician-scientist. By characterizing the fundamental biology astrovirus VA1, this work will enhance viral diagnostics and stimulate development of novel anti-viral therapies to treat infections caused by this virus.